High spatial resolution evaluation of subclinical regions of myocardial dysfunction in adult patients with tetralogy of Fallot

Project Summary
Surgical repair of tetralogy of Fallot (rTOF) has led to excellent long-term survival, yet rTOF survivors often
experience residual and progressive right ventricular (RV) dysfunction that burden these patients with adverse
cardiac events later in life. Given this growing population, there is a strong clinical need for techniques to guide
patient management. CT can be used to robustly obtain global measures of function in adult rTOF patients, but
regional dysfunction is not currently quantified. Strain evaluation can be limited by changes in ventricular
geometry and dyssynchronous contraction, both of which are common in rTOF patients. Myocardial work (MW)
– clinically measured as the ventricular pressure-strain loop area – can overcome this concern, as it is closely
related to myocardial perfusion and has been shown to be more independent of loading conditions. However,
ventricular pressure measurements do not capture regional heterogeneities in myocardial stress and the
impact of this approximation has not been explored. Further, the clinical utility of MW to detect early RV
dysfunction in rTOF patients with CT has not been established.
We have recently developed MWCT, an estimate of regional MW that combines regional endocardial strain
measurements from ECG-gated CT (RSCT) and RV pressure waveforms. The proposed project aims to
investigate MWCT as a quantitative tool to capture regions of subclinical dysfunction in adult rTOF patients. The
ability for MWCT to detect regional dysfunction will be compared to advanced MW estimates derived from finite-
element models of regional endocardial stress and RSCT. This aim will establish the simple, pressure based
MWCT estimate as an effective tool for characterizing regional RV performance. Further, this aim will compare
FE methods and establish an approach to measure MW as the endocardial stress-strain loop area within our
MWCT pipeline. Cross-sectional CT imaging will assess whether well-performing areas on MWCT agree with
cardiopulmonary exercise test (CPET) findings better than strain alone. Additionally, longitudinal evaluation via
functional class and CT imaging will be performed to assess whether the amount of discordant endocardium
(disagreement between regional work and strain measurements) corresponds with worsening symptomatology
and dysfunction respectively. This aim will demonstrate that capturing early dysfunction will improve clinical
care by detecting adverse remodeling prior to global changes. The long-term goal of this proposal is to
establish CT as a feasible method for evaluating regional RV function and develop robust quantitative tools for
early detection of dysfunction in all rTOF survivors.

Public health relevance
Project Narrative Residual and progressive ventricular dysfunction is common in adult survivors of repaired tetralogy of Fallot (rTOF), and conventional functional assessments reflect late-stage dysfunction that poorly predicts clinical outcomes. This proposal aims to investigate regions of subclinical right ventricular dysfunction in adult patients with rTOF using a CT-based approach. Detection of subclinical dysfunction with CT will improve long-term management of adults with rTOF by increasing accessibility to imaging-based functional assessment and characterizing impairment early and robustly, thus leading to more informed clinical decision-making.